Strategies to Innovate EmeRgENcy Care Clinical Trials Network (SIREN) - Network Clinical Center (Hub)

Project Summary
Oregon Health & Science University (OHSU) has the institutional experience, study team leadership, and
preexisting research networks to lead a successful enrollment hub for the Strategies to Innovate EmeRgENcy
Care Clinical Trials Network (SIREN). OHSU has specific experience managing multisite ED and EMS
research as one of ten regional enrolling hubs for the NIH/ NHLBI Resuscitation Outcomes Consortium (ROC)
and one of 22 enrolling hubs for the NIH/ NINDS Neurological Emergency Treatment Trials (NETT)
consortium. The OHSU SIREN study team includes principal investigators, co-investigators, and study/ data
managers for the OHSU ROC and NETT hubs. Our faculty team members are all federally funded clinical
scientists and include two of the top 10 NIH funded DEM investigators in 2015. We have over 100 personyears
of combined experience conducting multi-site research in EMS and ED settings. We leverage our extensive
experience with multisite ED/ EMS research and our study team leadership to: Aim 1. Create a SIREN
enrollment network to achieve an annual enrollment of at least 100 participants. 1a. Construct an ED Spoke
Network. We propose eight spokes that have the following qualifications: 1. Tertiary -care clinical infrastructure
to support all SIREN trials; 2. Strong history of ED research enrollment; 3. Pre -existing research collaborations
with the OHSU SIREN team. Our network serves a high volume and diverse (by race, ethnicity, payer)
population, and has enrolled >14,000 patients in the past two years. 1b. Construct an EMS Network. For out-
of-hospital SIREN studies, we will continue to use our extensive regional EMS research network created
through our ROC and NETT experiences. This includes 18 EMS agencies and 14 r eceiving hospitals that have
enrolled ~2,000 patients through ROC and NETT. 1c. Construct a Subspecialty Expert Panel. We build on
ROC, NETT and multiple other collaborative emergency care research to include experts in anesthesiology,
cardiology, cardiothoracic surgery, critical care, emergency medicine, hematology, neurology, neurosurgery,
and trauma surgery. Aim 2. Contribute to governance and scientific efforts of the national SIREN network. 2a.
Participate in SIREN governance efforts. Our SIREN study team members have held leadership positions on
ROC/NETT committees, including Executive, Trauma, Cardiac, Regulatory, EMS, and Publications. We will
continue similar governance committee participation for the SIREN network. 2b. Lead SIREN scientific efforts .
We have led ROC writing groups, served as facilitators for ROC trials, and co-authored >40 ROC reports. We
anticipate making similar contributions to SIREN. We propose two SIREN trials (Hypotensive Trauma
Resuscitation, Modified Endotracheal Tubes). In summary, OHSU has the institutional experience, study team
leadership, and pre-existing ED and EMS research networks to lead a successful SIREN hub.

Public health relevance
Project Narrative The SIREN consortium will conduct multi-site clinical trials in emergency department (ED) and emergency medical services (EMS) settings to improve the outcomes for patients with neurologic, cardiac, respiratory, hematologic, and trauma emergency events. Oregon Health & Science University has the institutional experience, study team leadership, and pre-existing ED / EMS research networks to lead a productive Oregon SIREN enrollment hub.